MOLECULAR CORE

Molecular Core Abstract: Dr. Harris will direct the Molecular Core and a staff of two full-time scientists. This essential Core will service the Program Project entitled "Critical Interactions of APOBECSs: Molecular Approaches to Novel HiV Therapies" by producing plasmid DNA constructs for APOBECS and Vif protein expression in E. coli and mammalian cells. We anticipate completing 10-20 constructs per week and providing a strong foundation for the program investigators.

Public health relevance
The interactions of the cellular APOBECS proteins and HIV Vif can dictate the fate of a viral infection. Our program scientists aim to provide the most comprehensive information to date on these life-or-death interactions, and our existing large collection of DNA constructs will be expanded even further to meet research objectives.